Molecular mechanisms connecting endocytic and junctional complexes with epithelial pathology in C. elegans

The goal of my research program is to delineate the inner workings of membrane-associated protein complexes
that are required to shape the form and function of tissues, and whose dysfunction leads to serious human
diseases. We use a multi-disciplinary approach that combines deep genetic screens, cutting-edge transgenesis
and live imaging in C. elegans, with biochemical assays of the homologous vertebrate complexes. We also
collaborate with experts in structural biology and proteomics to reveal mechanistic details and binding partners
of our purified complexes that we then further evaluate in vivo. Using this iterative approach, we have discovered
two classes of proteins that act in opposition to regulate the predominant portal of entry into eukaryotic cells,
clathrin-mediated endocytosis. The key player in this process, the clathrin adaptor complex AP2, is necessary
for linking clathrin to the cell membrane to drive endocytosis. We discovered that NECAP family proteins
recognize activated AP2 clathrin adaptor complexes that have been phosphorylated and return them to the
inactive state, while endocytic initiators called muniscins/FCHo stimulate inactive AP2 complexes to adopt an
intermediate conformation we have named ‘primed’. Together, these allosteric modulators of AP2 will enable us
to investigate how cells select endocytic sites and cargo for internalization, while ensuring non-productive or
inappropriate events are aborted. Recently, our studies to understand the physiological consequences of
inactivating AP2-dependent endocytosis at the organismal level have opened new lines of research. In C.
elegans, AP2 mutants exhibit a distinctive ‘cyst-like’ epidermal pathology. Through genetic screens, we have
recently discovered mutant forms of the Inversin complex that mimic this phenotype. In humans, mutations in
the Inversin complex cause lethal kidney cysts through unknown mechanisms, potentially linking what we see in
our C. elegans model to the human disease. We have now isolated other mutations in the Inversin complex that
reverse the cyst-like phenotype and will leverage these initial findings to determine the organization and output
of this enigmatic complex. We find that ‘cyst’ formation also depends on the worm homolog of ASPP family
proteins. Although poorly understood, mutations in ASPPs are clearly associated with heart, hair, and skin
pathologies in mammals. Our biochemical and functional assays suggest ASPPs form membrane-associated
arrays of protein phosphatase 1 (PP1). We will determine the molecular arrangement and activity state of this
novel mechanism of phosphatase regulation using single-molecule imaging and optogenetic techniques. Both
the ASPP and Inversin complexes localize to apical epidermal junctions; disrupting these complexes perturbs
patterning of the apical extracellular matrix and underlying cytoskeleton. How these poorly characterized
junctional complexes and membrane trafficking coordinate collagen-based and actomyosin networks remains
an open question that we will address in the next five years by combining our established approaches with new
ones, such as electron microscopy.

Public health relevance
PROJECT NARRATIVE Our cells constantly engulf macromolecules and internalize receptors, but we don’t know how this process of endocytosis helps cells establish polarized epithelial sheets required for our organs to function properly. Using unbiased genetic screens in C. elegans, we discovered connections between dysregulated endocytosis and two biomedically important protein complexes that lead to compromised skin integrity in these animals. Because mutations in these complexes also cause kidney, liver, heart, and skin diseases in children through unknown mechanisms, we will use genetic screens, protein biochemistry, and live imaging in our highly tractable nematode system to answer fundamental questions about how the complexes form and function to control cell-cell junctions and how their perturbation might lead to human pathologies.